RCMAR National Coordinating Center at UCLA

Project Summary/Abstract
Our nation is experiencing two conflicting trends: the population of older adults of color is growing
rapidly, but neither the number of researchers of color nor research output on this population reflects
these changing demographics. The Resource Centers for Minority Aging Research (RCMAR) focus on
mentoring, improving the skills, and building the networks of researchers from underrepresented
groups with a focus on aging and fostering state of the art research on minority elderly. Creating and
sustaining an infrastructure that promotes the development of national research networks, facilitates
cross-site and cross-program collaborations, maximizes the dissemination of RCMAR-generated science,
and informs the NIA’s program administration is best accomplished by a Coordinating Center (CC). UCLA
has run the CC for the RCMAR program for the past 15 years and is applying through this new
mechanism to use its experience and knowledge of the RCMAR program to continue as the RCMAR CC
for the next five years. This application proposes that we will: 1) Serve as the hub for the RCMAR
national program by facilitating and coordinating trans-RCMAR activities through providing logistical
support to RCMARs, 2) Foster communication and promote collaborative activities between RCMAR
sites and the NIA, and with a broad and diverse audience of researchers, educators and the community;
and 3) Refine and implement our tested evaluation plan for assessing the achievements of the RCMAR
program and of the RCMAR CC’s specific aims. We will build on past accomplishments in organizing
highly rated meetings and workshops, securing additional resources for cross-site collaborations, linking
RCMAR sites to broader networks, effectively disseminating RCMAR accomplishments to other
researchers and wider audiences, and building state-of-the-art IT infrastructure to support the program.
We will continue to innovate so that the network of RCMARs and Alzheimer’s RCMARs will have a higher
impact collectively than the individual centers would alone -- launching researchers on careers that will
contribute to new knowledge that will improve the health and well-being of both minority elderly and
other older adults.

Public health relevance
Relevance New knowledge that will improve the health of older adults is enhanced when the research workforce reflects the diversity of the populations being studied. The RCMAR National Coordinating Center at UCLA will continue to work with the growing RCMAR network to foster collaborations, shared resources, and dissemination capabilities among a national network of mentoring and training sites that are improving the skills and diversity of the next generation of NIH-funded researchers.